CHARACTERIZATION OF BONE AND MINERAL METABOLISM IN PRADER-WILLI SYNDROME

Previous studies in 6 males and 7 females (age 18-37) with Prader-Willi syndrome showed hypercalciuria and reduced bone density of the lumbar spine and femur. To determine the role of gonadal steroids in bone loss, bone density will be measured in twenty subjects with Prader-Willi syndrome treated with depo-estradiol (females) or testosterone cipionate (males) injection monthly for two years.